Utah Trial Innovation Center

This study is part of the NIH’s Helping to End Addiction Long-term (HEAL) initiative to speed scientific solutions to understand the basis of pain and enhance clinical pain management.

Public health relevance
Project Narrative The University of Utah Trial Innovation Center (TIC) works with the Clinical and Translational Science Award (CTSA) Hubs, other TICs, and the Recruitment Innovation Centers (RICs) to facilitate multi-center trials that will enable translation of biomedical discovery into therapeutic, diagnostic and preventive interventions to improve health across the human lifespan.